All of Us Pennsylvania

The PA Cares for Us Research Program (PA Cares) at the University of Pittsburgh (Pitt)/UPMC (University of Pittsburgh Medical Center) is a regional medical center (RMC) enrollment site for the NIH All of Us (AoU) Precision Medicine Initiative. As of November 13, 2017, we piloted an array of engagement methods, launched 3 enrollment strategies, and during the AoU beta phase fully enrolled 2005 participants who closely match our originally projected demographic distribution. We will now further leverage the continually expanding clinical footprint of UPMC and the infrastructure created by our NIH-funded Clinical and Translational Science Institute (CTSI), which we direct, to fully enroll at least 111,002 AoU participants to achieve a retained cohort of ?93,000 participants with: • Sufficient diversity to enable AoU’s million person cohort to achieve adequate power for evaluation of common disorders from infancy to old age. We will leverage UPMC’s expanding clinical operations in western and central Pennsylvania, our CTSI Community PARTners Core’s focus on eliminating health disparities, and our comprehensive PA Cares engagement plan that we designed with our stakeholders. Examples of resources that we will leverage to enroll adults, and eventually children, include: o 37 UPMC hospitals and >600 points of service across western and central Pennsylvania o 23 UPMC Senior Communities serving >2900 older adult residents o Hillman Cancer Center plus a network of >60 community cancer centers o >90 rehabilitation and long-term care facilities plus a planned disability hospital o Pitt/UPMC Aging Institute and partner organizations o Giant Eagle Pharmacy (219 locations throughout Pennsylvania) o >150 community organizations actively partnering with the CTSI Community PARTners Core, including close collaborations with the Urban League of Greater Pittsburgh, FOCUS Pittsburgh, and several Latino organizations o PA Cares Stakeholder Advisory Board (SAB) representing diverse groups, including those underrepresented in biomedical research (UBR), and participant partners o 14 UPMC hospitals located in rural counties (e.g., UPMC Altoona, UPMC Bedford, recently acquired Susquehanna Health System) o UPMC Children’s Hospital of Pittsburgh (FY17: 12,333 inpatient stays; 9,693 observation stays; 146,748 emergency/express care visits; 23,389 surgeries; >1M outpatient visits) o UPMC Children’s Community Pediatrics network (>40 practices, >200 providers, >200,000 patients) o UPMC Magee Women?s Hospital (>11,000 deliveries annually) • Intentional and directed over-sampling of populations historically underrepresented in biomedical research to enable AoU to have sufficient power for statistical analyses in order to help understand the specific health conditions and disparities affecting these population groups. We will use novel tools, design thinking approaches, targeted messaging, and nimble PA Cares enrollment methods, such as: o Pitt+Me Research Participant Registry (>134,000 consented participants who receive study invitations based on electronic health record (EHR) data, demographics, and preferences; >9,500 new Registry enrollees in past 2 months alone) o NIH/NCATS Accrual to Clinical Trials (ACT) network of linked EHRs to target specific demographic groups (across 37 UPMC hospitals & >600 offices and deployment by at least 18 AoU RMC sites by 2019) o TrialSpark (social media tool for targeting specific demographics) o UPMC Altoona and Bedford Hospitals with expansion to UPMC Susquehanna and Pinnacle Health Systems (rural and urban central PA) and UPMC Northwest, Horizon, and Hamot Hospitals (rural and urban northwestern PA) o Nimble pop-up engagement and enrollment teams to reach Community Health Centers, Federally Qualified Health Centers, Free Clinics, and other specialty care venues that care for UBR populations • A broad range of genetic backgrounds, dietary, lifestyle, and environmental exposure assessments. We will capitalize on the demographics of western and central Pennsylvania, including: o UPMC’s diverse catchment area (Figure 1) o Stable aging population with longitudinally documented exposure to mining, steel, chemical, manufacturing, agriculture, and other industries o Large Mennonite and Amish communities serviced by our providers • A broad array of clinical and laboratory information via EHR, not limited to any single disease through: o UPMC EHR, which contains comprehensive in- and outpatient data collected since 2004 o CTSI Research Data Warehouse, which comprises structured clinical data for each patient that has been aggregated from UPMC’s EHR systems and includes demographics, diagnoses, procedures, medications, and laboratory test results • An engagement, recruitment and implementation process that ensures a high follow-up rate and comparable follow up rates across diverse population groups. Our retention plans are based on the concept of providing value to participants and leverages our previous experiences. We will: o Deploy our Pitt+Me recruitment framework for mail/email communications with PA Cares participants o Be guided by our SAB (we embrace an inclusive decision-making process to develop and adjust methods to meet participants’ needs) o Leverage the MyUPMC health portal, which can be used to engage and recruit from among >540,000 patient users and provide general education about types of results returned by AoU o Leverage UPMC Health Plan communications with its 3.2 million members o Employ multi-media engagement and retention tools created by Wondros based on a human-centered design approach o Employ efficient project management with guidance from The Chartis Group (process management)